Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Ohio State University Vision Sciences Research Core Program (OSU-VSRCP) is directed by Sayoko
Moroi, MD, PhD, Dept of Ophthalmology and Visual Sciences (DOVS). The OSU-VSRCP has established
scientific connections and collaborations across five academic units (i.e., College of Medicine (COM), College
of Optometry (COO), College of Engineering (COE), College of Veterinary Medicine, College of Arts and
Sciences) and newly engaged Nationwide Children’s Hospital (NCH). This community of vision scientists
spans basic-translational-clinical research from ophthalmology, optometry, neuroscience, engineering,
veterinary ophthalmology, psychology, and pediatrics. Dr. Moroi has commitment from Deans and Chairs to
purchase equipment, support data science, assign scarce space, increase collaborations among NEI-funded
PIs, and pilot programs for preliminary data. The leadership and vision scientists are aligned with the NEI PAR-
20-051 ‘to enhance the capabilities of participating NEI-funded investigators and the institution for conducting
vision research.’ This NEI P30 has three scientific cores: Core A. Structural and Functional Assessments Core
(SFA) with an agreement for machine shop services, Core B. Biostatistics, Bioinformatics and Genetic
Analysis Core (BBGA), which combines traditional statistics and statistical genetics, and Core C. Image
Analysis and Data Science (IADS) Core for the timely need of expertise in artificial intelligence for imaging and
large data sources. These Cores were determined from a survey of 61 vision scientists. Each Core has a
Director and Co-director, with at least one holding an NEI R01. The synergy among this community has been
established with monthly ViSOR (Vision Sciences OSU Research) seminars. Synergy between Cores has
been defined by the Steering Committee composed of the PD, Core Directors and Co-directors, who represent
DOVS, Dept. Neuroscience, Dept. Biomedical Informatics, Dept. Computer Science (COE), and COO. The
synergy between Cores will coincide with monthly ViSOR meetings. In addition, an Advisory Group will provide
guidance twice a year to the Steering Committee. The Administrative Core has four aims designed for the
successful implementation of our OSU-VSRCP: Aim 1. Policy and oversight; Aim 2. Communication with users;
Aim 3. Tracking, reporting and fiscal activities; and Aim 4. Promoting collaboration. This proposed P30 core
intends to maximize efficiency, offer centralized access to equipment and expertise that would be difficult,
costly or impractical to duplicate in individual labs, and use protocols to ensure best practices to perform
science at the highest standard. Credit to Core A Director Fischer and Co-director Cebulla for setting the
collaborative culture of equipment sharing to enable initiating OSU-VSRCP. The expected outcome is
increased collaboration for successful new proposals with the shared overarching goal to prevent blindness,
restore vision and develop cures for eye diseases.